Catalyzing Systemic Change at Drexel University to Support DiverseFaculty in Health Disparities Research

PROJECT SUMMARY
The Evaluation Core (EC) for the Drexel FIRST Program has as its main goal to evaluate, using mixed
methods, and in coordination with the FIRST Coordination and Evaluation Center, multi-level outcomes
(individual, mentors, department, institution) including an evaluation of scientific impact of the FIRST Faculty
hires. The efforts of the EC are grounded in theoretical frameworks reflecting equity, inclusivity and
intersectionality, and are guided by a logic model conceptualizing our change efforts, the activities planned to
contribute to desired changes, the immediate outputs and ultimate outcomes that will be tracked and
documented. Specifically the EC will: (1) work closely with the designated FIRST “Coordination and Evaluation
Center” to help design and implement a uniform and systematic core data set across FIRST Program
awardees; (2) develop and implement an evaluation strategy specific to Drexel FIRST Program activities; (3)
provide formative evaluative reports to the Coordination and Evaluation Center and our Administrative and
Faculty Development Cores to inform programmatic adjustments and improvements; and (4) evaluate impacts
at multiple levels (individual FIRST faculty hire, department, college and institution) of Drexel’s FIRST Cohort
hires on outcomes ranging from individual ratings of inclusivity and social isolation to organizational readiness
and climate. Furthermore, we will evaluate scientific impact of FIRST faculty in advancing the science of health
disparities research using the National Institute of Minority Health and Disparities framework to identify
domains and levels addressed in their scholarship. Finally, as our long-term goal is to sustain a research
culture of inclusive excellence, the EC will establish an approach including tracking tools for continuous
institutional self-assessment, analysis and feedback, assuring accountability and integration of the FIRST
Program into the fabric of institutional life at Drexel during the life of the grant and thereafter. The specific aims
of the Evaluation Core are: (1) To characterize and track the various components that compose the FIRST
program at Drexel University; (2) To evaluate the impact of the FIRST program at Drexel on institutional
outcomes including organizational research climate and implementation and adoption of FIRST strategies,
policies, and processes to promote inclusive excellence; (3) To evaluate the impact of the FIRST program at
Drexel on outcomes defined at the level of the hiring academic units and the new faculty hires themselves,
including unit culture, mentoring environment, sponsorship, other cohort experiences (social isolation, support)
and career progression opportunities including productivity as reflected in publications, presentations,
collaborative opportunities, grant submissions and funding successes; and (4) To evaluate the impact of the
FIRST Cohort on advancing the science of health disparities research. Importantly, the EC will provide a
summative evaluation as to whether we have achieved the goal of inclusive excellence of the Drexel FIRST
Program and how it can be sustained beyond funding.